Serum Sample Collection for Determining the Genetic Risk of Sporadic Myocarditis

This IAA provides additional support for an ongoing Population Genetic Anaylsis study that is fine mapping and replicating the associations between smallpox vaccine-associated myocarditis and polymorphisms in two genetic loci. The additional support will cover the cost of transferring serum samples from the Department of Defense to the University of Washington.